Multiplexed detection of cell-free M. Tuberculosis DNA and its drug-resistant variants in blood

ABSTRACT
Every year 10 million people fall ill with tuberculosis (TB) and 1.5 million people die from TB – making it the
leading cause of death from infectious disease – but TB can be difficult to diagnose. Extended M. tuberculosis
(Mtb) cultures are still often used for diagnosis. PCR-based assays (e.g. Xpert MTB/RIF) that detect TB DNA
can provide more rapid results, but require special equipment and, like Mtb culture, exhibit reduced sensitivity
when employed to analyze sputum from individuals with extrapulmonary TB or compromised immune systems.
Blood-based TB assays should detect all forms of TB, but current tests analyze the immune response to Mtb
antigens and cannot distinguish active and latent TB. Sensitive detection of Mtb-derived cell-free DNA (cfDNA)
in the circulation, however, represents a potential new means for enhanced TB diagnosis. Circulating cfDNA is
rapidly degraded after its release and disease-associated cfDNA levels in blood can rapidly change in response
to pathologic changes and physiologic responses. This short half-life can enable “real-time” cfDNA analyses
required for accurate evaluation of the current status of active Mtb infections and rapid granular evaluation of
Mtb treatment responses. However, the limit of detection (LoD) of current PCR-based assays are not sufficient
to reliably detect Mtb cfDNA in blood. We have established a CRISPR-Cas12a-based detection system that can
ultra-sensitively detect trace amount of SARS-CoV-2 RNA in blood to diagnose COVID-19, predict disease
severity, and evaluate infection resolution. We have adapted this approach to develop a blood-based multiplexed
CRISPR-mediated TB diagnosis (CRISPR-TBD) assay that can detect circulating Mtb cfDNA, including SNPs
responsible for drug-resistant TB. Our preliminary data from longitudinal serum samples of patients undergoing
TB treatment provide strong proof-of-principle evidence for the clinical utility of this platform. We have adapted
this approach to a paper strip-based point of care (POC) CRISPR-TBD detection platform suitable for use in
resource-limited regions with high TB burden, without decreasing assay sensitivity. We now propose to: 1)
systematically optimize all CRISPR-TBD paper strip assay steps to improve quantitative detection of Mtb-cfDNA
in POC settings; 2) evaluate the performance of this POC assay to diagnose pulmonary and extrapulmonary TB
and to identify drug-sensitive and -resistant TB cases; 3) quantify Mtb-cfDNA changes in serum during TB
treatment as a measure of treatment efficacy or failure and for early detection of nascent drug resistance; and
4) in-field validate the diagnostic performance of this POC assay in an independent TB patient cohort when
performed in a clinical laboratory in a high endemic TB region and evaluate in parallel the performance our
predictive Mtb-cfDNA model for TB treatment.

Public health relevance
NARRATIVE Tuberculosis (TB) is the leading cause of death from infectious disease worldwide, but can be challenging to diagnose due to the poor performance of current diagnostic tests that require sputum or tissue biopsies that can be difficult to obtain in certain patient populations, including young children, and this situation has worsened due the reallocation of healthcare resources during the COVID-19 pandemic. We thus propose to employ a novel CRISPR-based paper strip point-of-care assay to detect and quantify Mycobacterium tuberculosis-derived cell- free DNA (Mtb-cfDNA) in blood to simplify sample collection for the diagnosis and treatment evaluation of drug- sensitive and -resistent TB cases. Based on our preliminary studies, we are confident that this assay will improve TB diagnosis in all patient populations, including the diagnosis of early disease in young children, and allow consistent evaluation of Mtb-cfDNA changes that should reflect the systemic effects of anti-TB treatment, both of which are required to improve TB control efforts in resource-limited areas with high endemic TB levels.